Shared Resources Management

SHARED RESOURCE MANAGEMENT: ABSTRACT
Shared resources play a critical role in enhancing and supporting the scientific, outreach, and educational
endeavors of The University of Kansas Cancer Center (KUCC) and its 171 members. A proposed shared
resource is given consideration for official KUCC Cancer Center Support Grant (CCSG) shared resource status
based on the number of members served as well as the depth and breadth of science enhanced. KUCC
continually assesses its shared resources to ensure they have distinct services to avoid overlap of support,
have a solid user base of KUCC membership utilizing the resource, are cost-effective, have systems to track
utilization, are accessible to all members across our four campuses, and have charge-back rates that have
been approved by institutional finance and meet the NIH guidelines. All shared resources adhere to the
following prioritization for providing support: 1) KUCC members with NCI grants or applying for NCI grants and
KUCC pilots; 2) KUCC members with cancer or cancer-related grants funded by other NIH institutes or other
peer-reviewed grants as defined by the NCI or applying for such grants; 3) KUCC-sponsored non peer-
reviewed projects; 4) Other grants or contracts that are not peer-reviewed (e.g., philanthropy or industry
funded); and 5) Unfunded projects. These priorities place the highest emphasis on peer-reviewed funded
research projects as a means of assuring that support is provided to high-quality research. Continual feedback
has been ascertained using surveys, focus groups, individual member input, external experts, and assessment
and guidance by KUCC leadership. The annual shared resource survey in 2020 showed 94-100% satisfaction
for all shared resources. A key focus during the previous grant cycle has been to enhance shared resource
access across all four campuses as well as stimulating more use across membership and the utilization of
multiple shared resources. Member usage spans all research programs and campuses and has grown
considerably from 99 in 2010, to 113 in 2015 and now 137 in 2020. KUCC also tracks super users, members
who utilize three or more shared resources within a year. The number of super users has grown from nine in
2010, to 23 in 2015, to now 52 in 2020. Since our initial application, usage has increased across all three
programs: Cancer Biology has gone from 41% of members utilizing shared resources to now 78% of members
utilizing shared resources; Cancer Prevention and Control has gone from 69% of members utilizing shared
resources to now 78% of members utilizing shared resources; and Drug Discovery, Development and
Experimental Therapeutics has gone from 54% of members utilizing shared resources to now 84% utilizing
shared resources. In 2019, KUCC undertook a strategic planning effort to identify enhancements for shared
resources to meet the ever-changing needs of members over the next five years. These enhancements totaled
over $5M in requests and initial investments have already begun with an expected outlay of additional support
of over $1M in 2021.